Specialized post-transcriptional mechanisms of gene expression in quiescence

Abstract Specialized post-transcriptional mechanisms of gene expression in quiescence
Vision Quiescence (G0) is an assortment of reversible, cell-cycle arrested phases, that permits cells to avoid
death due to harsh conditions or stress. Our studies uncovered powerful RNA regulators, and modifications in
G0 cells, revealing inhibition of conventional translation and its replacement by non-canonical mechanisms to
enable specific gene expression for G0 roles and survival. Based on our data, G0 cells are perpetuated by
specialized post-transcriptional mechanisms that elicit distinct gene expression. G0 cells switch to a gene
expression profile that maintains the transient arrested state, enables survival, and retains the ability of the cell
to re-enter proliferation. This permits important G0 functions: survival of G0 drug resistant cancer stem cells,
immune cell extravasation, tissue regeneration and development by dormant stem cells. G0 is important in
cancer and immunity, producing critical cytokines to promote inflammation and tumor persistence. G0 is poorly
understood despite its medical significance. The objective of my research is to investigate post-transcriptional
mechanisms and regulated gene expression in G0 in vitro and in vivo to understand G0 roles and survival.
Premise based on our research findings The key finding of our studies is that conventional translation is
inhibited by G0 signals and replaced by non-canonical factors that enable specific expression of genes that are
critical for survival. Significantly, such non-canonical factors alter translation start site selection, expanding the
proteome by creating new frames (PNAS 2014). We identified noncoding microRNAs, associated RNA-protein
complexes (RNPs), and non-canonical translation factors that mediate select expression of few immune and
cell state regulators in G0 (Molecular Cell 2016). Our data revealed signaling changes that modify RNPs in
G0 to enable specific gene expression, which allowed targeting of drug resistant G0 in disease (Biorxiv/
418715). Our studies indicate important layers of undiscovered regulation: modification of ribosomes, mRNAs
and RNPs and associated non-canonical translation. Characterization of G0 post-transcriptional mechanisms,
will provide insights into the specialized gene expression and mechanisms that underlie G0 survival in disease.
Directions in the next 5 years First, profiling, purifications, depletions, mutations, and biochemical analyses
of snoRNAs and ribosomes, will map snoRNPs and ribosome modifications, providing insights on changes to
the translation machinery underlying gene expression in G0. Second, required modifications on mRNAs,
associated regulatory RNPs, non-canonical translation factors, translated targets and unique start sites in G0
will be identified. These data will be verified in vivo to uncover the G0 translatome, expanded at the translation
frame, and will reveal post-transcriptional mechanisms of gene expression that impacts G0 roles and viability.
Impact These studies uncover new insights into post-transcriptional mechanisms, provide a map of ribosome
and mRNA modifications, and translation frames in G0, and their impact on G0 roles and survival in disease.

Public health relevance
Narrative Specialized post-transcriptional mechanisms of gene expression in quiescence Quiescent cells are versatile cells that are transiently arrested—and thus withstand harsh conditions to avoid death; these resurge subsequently upon favorable conditions and thereby play a critical temporally controlled role in medically important conditions such as leukemia persistence, immune disease, tissue regeneration and development. Based on our findings, quiescent cells are maintained by RNAs, powerful molecules that control immunity, development and disease, which mediate chemical modifications to produce essential factors for such cells to survive. The overall vision of our research is to characterize the role and targets of RNA based mechanisms and modifications that underlie quiescence, their roles and their survival in disease.